Drug abuse and HIV-associated pulmonary vascular injury

Project Summary
This administrative supplement proposal is to examine if the circulating endothelial-derived small
extracellular vesicles (EVs) can be leveraged as a non-invasive biomarker of pulmonary vascular dysfunction
using a novel microfluidic chip-based platform. Lately, EVs have emerged as important mediators in cell-cell
communication, and the role of alterations in their cargo has been implicated in various diseases, including
pulmonary hypertension (PH). However, to allow for rapid integration into clinical practice, there remains a
need for an inexpensive, user-friendly approach to the quantitative analysis of EV-linked putative biomarkers.
So, in this supplement, we intend to leverage a novel microfluidics-based bioanalytical platform to overcome
these technological barriers and the procedure complexity of isolating EVs required for screening large patient
cohorts. Premature aging is one of the important factors contributing to the increased prevalence of
cardiopulmonary diseases in people living with HIV (PWH) and pulmonary vascular endothelial cells have been
reported to be highly senescent in PH. Using a highly sensitive nanoengineered chip-based bioanalytic
platform for the detection of EC-EVs and a targeted proteomics approach, we propose to test the central
hypothesis that the higher numbers of circulating endothelial-derived small EVs (EC-EVs) in PWH carry pro-
aging factors that are associated with an increased prevalence of HIV associated PH. This supplement request
is within the scope of an active parent NIH award on HIV-PH, and the innovative microfluidic approach is
expected to expedite the analysis of a selective sub-population of plasma-derived EVs with increased
sensitivity, specificity, and efficiency. This state-of-the-art technology will also allow for future customization of
new putative EV-linked biomarkers in larger clinical studies. Furthermore, this technology may be adapted in
the future to also identify markers of other vascular pathologies such as frailty and cerebrovascular and renal
pathologies, which are very common in PWH.

Public health relevance
Project Narrative The proposed study will analyze endothelial cell-derived extracellular vesicles in HIV infected individuals using microfluidics platform in an attempt to identify potential biomarkers of vascular dysfunction and HIV- associated pulmonary hypertension. The successful completion of this study is expected to have a significant positive effect on human health because it will advance our understanding of the role of endothelial cell-derived extracellular vesicles and their protein cargo in HIV-mediated vascular injury, leading to the development of more accurate diagnostic tests and, ultimately, treatment targets for preventive and therapeutic interventions.